Administrative Core

ABSTRACT - ADMINISTRATIVE CORE
The Administrative Core of the Mayo Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA)
will provide support for the scientific and administrative work of the Methodology and Resource Cores and
expand the TJA research community with the overarching goal to accelerate innovative and interdisciplinary
clinical research in TJA. The Administrative Core will leverage the unique expertise, data and infrastructure
resources of the Mayo Clinic, including the Center for Clinical and Translational Science (CCaTS). The
Administrative Core leadership has national recognition in TJA practice and research and will manage the
CORE-TJA activities with support from the Executive Management Team composed of the Administrative Core
Director, Associate Director, Directors of Methodology and Resource Cores and a CCaTS representative. The
Executive Management Team will focus on integration of CORE-TJA within the institution, quality and
efficiency of CORE-TJA activities through administrative and scientific oversight, communication and outreach
efforts with professional societies and other stakeholders, and continuous improvement using robust evaluation
metrics with strategic input from the External Advisory Committee. The Specific Aims of the Administrative
Core are: (1) To provide leadership and the overall organizational infrastructure to CORE-TJA, strengthening
its role as a national methodology hub for clinical research in TJA, (2) To stimulate and oversee regional and
national collaborations, (3) To oversee and ensure the quality and efficiency of CORE-TJA activities including
pilot and feasibility studies, and (4) To evaluate key metrics for success related to all CORE-TJA activities.
Collectively, the Administrative Core is well matched to needs of the TJA research community in securing the
national position of CORE-TJA as the methodology hub of clinical research in TJA.

Public health relevance
NARRATIVE The Mayo Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA) will provide methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that will be addressed by the CORE-TJA include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.